ADMINISTRATION OF DEHYDROEPIANDROSTERONE TO ELDERLY SUBJECTS IMMUNIZATION

A placebo-controlled randomized trial of DHEAS in humans given Hepatitis Recombinant Vaccine to determine if the response to hepatitis vaccination can be improved in the elderly.